Intercellular Communication and Pheromone Maturation in Gram-Positive Bacteria.

Project Summary
Gram-positive bacteria process and release small peptides, or “pheromones”, that act as critical signals for the
induction of adaptive traits including those involved in virulence. One class of small signaling pheromones is
the cyclic auto-inducing peptide (AIP), which regulates the expression of genes that orchestrate virulence and
persistence in Staphylococci, Listeria, Clostridia, and Enterococci. Defects in cyclic AIP production and
signaling can compromise virulence traits of these microbes, underscoring the relevance of peptide-based
signaling to health and disease. Staphylococcus aureus harbors a cyclic peptide signaling system known as
the accessory gene regulatory (Agr) system. This “quorum sensing” system depends on the synthesis,
processing, and export of a cyclic AIP, derived from its precursor protein, AgrD, for function. AIP signaling
through Agr leads to the production of S. aureus virulence factors, whereas disruption of signaling causes
significant attenuation in skin and lung infection models. Despite clear connections between Agr and S. aureus
pathobiology, there exist major gaps in our knowledge of the mechanics of AIP biosynthesis. Most notably: (i)
the proteins needed for peptide processing of AIP have not been elucidated; (ii) a transporter for AIP or its
leader peptide has not been identified; (iii) differential processing of AIP variants has not been investigated;
and (iv) conservation in cyclic peptide processing events between bacterial species is not known. In this grant,
we provide data related to our discovery of a putative peptidase in S. aureus, MroQ, that we hypothesize acts
directly or indirectly on Agr system components to promote the final steps in the processing and/or export of
AIP. The overall goals of this grant are to interrogate the previously unknown mechanics of cyclic peptide
maturation in S. aureus and provide insight into the potential conservation of function in Gram positive
pathogens. Aim 1 will define how MroQ promotes AIP processing, export, or both. Aim 2 will interrogate the
extent with which MroQ interacts with Agr system or other membrane components and will use biochemistry to
test if MroQ directly cleaves AgrD. Aim 3 will determine the extent with which MroQ promotes activity of Agr
variants both within species and among other species and identify the AgrD sequence characteristics that
dictate MroQ specificity.

Public health relevance
Project Narrative Bacterial intercellular communication is required to induce adaptive traits and community behaviors such as competence, biofilm formation, and virulence gene expression. A range of Gram positive bacteria, including highly pathogenic species, use small cyclic peptides to signal to nearby bacterial cells. We will investigate newly uncovered mechanics of cyclic peptide maturation in Staphylococcus aureus with goals of improving our understanding of bacterial cell-cell communication and promoting development of novel therapeutics.